TIPS: Training in Perioperative Science

The training program, open to MDs, typically at the end of their residency training is designed to
provide 2 years of research training in perioperative science. The major goal of this training
program is to provide the highest caliber research training to residents and postdoctoral fellows
in four Specific Themes originating from existing strengths of our faculty within Anesthesiology
and at Vanderbilt University Medical Center: 1) Mechanisms and Management of Pain; 2)
Perioperative Stress Biology and Outcomes; 3) Perioperative Health Services and Translational
Research; and 4) Personalized Medicine and Pharmacogenomics. Each of these themes directly
relates to the overarching aim of the program – to train the next generation of scientists to create
new knowledge and translate it into best evidence for personalized perioperative care and pain
management at a population level. The training faculty will consist of an exceptionally strong
collection of physician-scientists and basic scientists who offer superb interdisciplinary research
training opportunities in 7 different academic departments. The training program will accept two
new trainees per year (staggered, maximum of 4 participants per year). Clinicians who show
exceptional aptitude for successfully pursuing an academic research career and occasional PhDs
who demonstrate best aptitude to develop towards independence will be considered for
participation. Each participant will commit to a 2 year basic science, clinical and/or translational
research project with 75% effort and will receive over the 2 year period in addition to their research
project training, coursework training in research related processes such grant writing,
publications, ethics, and responsible conduct of research. This training will prepare them to utilize
the skills they acquire in the pursuit of future academic research careers.

Public health relevance
Project Narrative This training program in basic, clinical, and translational research will train basic and physician scientists in mechanisms and management of pain, perioperative stress biology and outcomes, health service and translational research, and personalized medicine and pharmacogenomics. The program will prepare future researchers for the unique challenges associated with the optimization of perioperative care.